GLUCOSE, LIPID AND LEUCINE OXIDATION IN IDDM AND PUBERTY

The specific aims of this research are to (1) determine the rate of oxidation of glucose, lipid, leucine and to (2) determine the relationship between leucine oxidation and glycemic control.